Molecular Genetics

PROJECT SUMMARY (See instructions): The major goal of this COBRE application is to foster the development of COBRE investigators in the Center of Pediatric Research and help them to succeed in their research programs. This will be carried out by a multidisciplinary group of researchers at Sanford Research/USD who are dedicated to basic and translational biomedical research. To promote the growth of the only multidisciplinary training program for pediatric basic and translational studies in South Dakota, the Sanford Research/USD will establish infrastructures to provide essential and centralized laboratory service to COBRE project leaders. The Molecular Genetics Core facility is a laboratory in the Children's Health Research Center offering efficient, high quality and affordable molecular genetics services for COBRE project leaders and other researchers in Sanford Research/USD. The state-of-the-art, high-throughput equipment in the laboratory will enable a wide range of molecular genetics assays, including extraction of nucleic acids from tissues and cells, quantitative and qualitative analysis of nucleic acid samples, gene expression analysis and training. The Molecular Genetics Core facility will provide personalized services for COBRE project leaders from experimental design to assay execution and data analysis. A plan is developed for a sustainable Molecular Genetics Core facility to serve the needs of COBRE project leaders and other researchers in Sanford Research/USD. By providing the funding, resources and core lab services, Sanford Research/USD will promote the advancement of this core group of scientists to build a stronger pediatric research program, and ultimately increase the number of NlH-funded biomedical researchers in South Dakota.

Public health relevance
RELEVANCE (See instructions): The Molecular Genetics Core will provide services and expertise for molecular genetic assays and techniques. These services are critical for advancing studies involving elucidation of gene function in health and disease.